C. albicans-intrinsic mechanisms defining gut colonization

Abstract (From Parent R01)
The fungus Candida albicans is a frequent commensal of the gastrointestinal (GI) tract but is also an
important cause of both mucosal and systemic disease. The GI population is particularly relevant to human
health as cells can translocate out of this niche to cause disseminated infections. C. albicans cells in the gut
also play key roles in regulating local and systemic immune responses that can be either beneficial or
detrimental to the host. There is therefore a pressing need to understand how C. albicans colonizes the GI
tract and to define how changes to the commensal environment impact fungal behavior. Attention has
focused on the ability of C. albicans to transition between yeast and filamentous states, with yeast-locked
cells shown to exhibit higher fitness in the GI tract than wild-type cells. However, these studies have
extensively relied on models that require antibiotic supplementation for stable fungal colonization. In
preliminary studies, we examined C. albicans fitness in colonization models without antibiotic treatment.
Surprisingly, we show that yeast-locked cells are defective for gut colonization in hosts containing high
bacterial loads, including those colonized with defined bacterial consortia. Furthermore, we demonstrate that
Candidalysin, the first toxin identified in a human fungal pathogen, is critical for gut colonization in hosts
carrying high bacteria loads but not in those given antibiotics, indicating that this factor supports fungal
commensalism by enabling competition with the bacterial microbiota. To build on these observations, we will
examine how C. albicans morphology (and co-regulated genes) determine GI colonization fitness.
Experiments will utilize a variety of murine GI models carrying native or defined bacterial populations to
determine how interkingdom interactions influence fungal gut commensalism (Aim 1). We are particularly
interested in determining how Candidalysin regulates fungal fitness in the GI niche, and whether this toxin
acts intrinsically on fungal cells, to inhibit bacterial cells, or via its impact on host epithelial cells (Aim
2).Together, these experiments will provide novel insights into the fundamental mechanisms used by C.
albicans to colonize the gut, including the role of Candidalysin toxin in increasing the fitness of fungal cells
in the competitive GI niche. Given the importance of gut colonization to fungal-host interactions, these
experiments are critical for understanding how C. albicans operates as a human pathobiont.

Public health relevance
Project Narrative: This project aims to uncover the mechanisms that enable C. albicans to establish itself as a commensal organism in the gastrointestinal tract and to explore how it interacts with resident bacterial communities and influence host immune responses. The findings will enhance our understanding of fungal-bacterial-immune dynamics in the gut and support the development of targeted therapies to prevent serious infections caused by this opportunistic pathogen.